Advancing community-driven optimization for equitable implementation of early childhood mental health prevention in pediatric learning health systems: Mental Health, Earlier ALACRITY Research Center

PROJECT SUMMARY
This Center strategically addresses a key developmental driver of the youth mental health crisis: Currently, 1 in
5 children has an identified mental health problem as early as age 3. This Mental Health, Earlier (MHE) ALAC-
RITY Research Center addresses the grand challenge of achieving population-level impact of early childhood
mental health prevention efforts within routine care. The Center targets toddler transdiagnostic behavioral vul-
nerability at this pre-clinical phase to impact lifespan mental health. Pediatric primary care is a promising setting
for achieving population impact, with broad reach to historically marginalized communities. Taking this to scale
requires: (1) systematic incorporation of equity principles across all levels of implementation to ensure equitable
adoption and reach of evidence-based interventions across diverse communities and families; and (2) leveraging
novel pragmatic and accessible developmentally- and ecologically-based decision and prevention tools feasible
for primary care integration. The Center is Northwestern based, including longstanding partnerships with Lurie
Children's Hospital, community health centers within AllianceChicago's practice-based research network, and
University of Utah Health. The Center's connective thread is an equity-oriented implementation framework, hu-
man-centered design methods, and a novel Roll-Out Implementation Optimization trial design, which systemat-
ically engages partners in strategy optimization. Center Aims: (1) Develop novel caregiver-focused, system-,
and clinician-level strategies to advance equitable implementation of early mental health interventions in pediat-
ric primary care; (2) Address the unique needs of diverse communities and families via engagement in culturally
attuned, evidence-based prevention services; (3) Create a national resource for equitable implementation of
childhood mental health innovation in pediatric primary care, including fostering a cadre of scientific and work-
force leaders and experts, and an open access toolkit. Center Signature Project (SP) and Research Projects
(RPs) innovate, implement, and integrated evidence-based equitable interventions and strategies, with RPs test-
ing novel approaches and/or levels of inquiry designed to address recognized, but understudied, barriers: SP
This cluster randomized trial implements an evidence-based toddler mental health risk decision tool with coordi-
nated care to the Family Check-Up Online to support parenting and toddler self-regulation; RP1: Deploys digital
case-based training to improve clinician confidence and family-centered communication about toddler mental
health risk within an anti-racist, culturally grounded framework; RP2: Adapts an evidence-based adjunctive digital
single-session intervention to increase families'mental health services use; RP3: Explores unintended conse-
quences of early mental health prevention via an integrated bioethical-implementation framework , including
inequitable distribution of negative consequences. A Community & Scientific Engagement & Administrative Core
and Methods Incubation Core provide vision, coordination, methodologic and career development supports to
advance equitable implementation of mental health promotion for diverse primary care systems and families.

Public health relevance
PROJECT NARRATIVE This Mental Health, Earlier ALACRITY Center addresses a key development driver of the youth mental health crisis: 1 in 5 children have a mental health diagnosis by the age of 3 but existing evidence-based tools and approaches have failed to be systematically implemented in routine primary. To achieve population reach, the proposed Center advances scalable approaches to pediatric primary care-based early mental health promotion via targeting toddler transdiagnostic behavioral vulnerability at the preclinical phase to impact lifespan mental health. The Center's unique equitable implementation framework, tools and strategies are poised to foster mental health equity, promote resilience, and reduce the public health burden of early-onset severe mental health problems for children and families with diverse lived experience, with innovations including quantitative tools for bias reduction, digitally delivered prevention for increased access, ongoing integration of community partner priorities and values, interactive provider training to improve confidence in developmentally-based decision making and accessible strategies for bridging the screening to services gap via heightened family engagement.